Research Career Scientist

PROJECT SUMMARY (CURRENT RESEARCH AND GOALS)
My research goals are to improve the mobility of Veterans with lower limb amputation, reduce their risk of
injury, and enhance their comfort while wearing a prosthesis. I use randomized clinical trials to determine the
efficacy of commercially available devices to guide clinical decision-making with evidence. If commercial devices
fall short of expectations, I explore innovative approaches that could dramatically advance the state-of-the-art.
Individuals with lower limb amputations sometimes see their mobility curtailed due to residual limb skin
injuries. Infrequent, but high stresses from impact loads (e.g., jumping or fast walking) or torsion (e.g., rapid
changes in direction) can certainly cause skin injuries, but so can repetitive insults from the thousands of steps
taken each day. While clinicians have many commercially available prosthetic ankle-feet to choose from, none
mimic the motion of the natural limb in all regards. To discover if a prosthesis with more natural motion would
have better patient outcomes, I developed a torsionally adaptive prosthesis (TAP) that couples sagittal plane
motion of the ankle (plantar- and dorsi-flexion) with transverse plane motion (external and internal rotation).
Funded by a VA Merit Review, our recently concluded clinical trial found a 6:1 sagittal:transverse coupling ratio
created a more natural motion and minimized residual limb torsion. Providing this coupling might improve
mobility by allowing longer walking bouts without injury, but a mechatronic limb like the TAP would be unlikely
to leave the lab. Striving for a commercially viable alternative, my team and I invented and patented the Pivot-
Flex Foot, a passive prosthesis capable of 6:1 coupled motion. Using a validated finite element model, we are
fabricating Pivot-Flex feet in different sizes and stiffness categories needed for an upcoming clinical trial.
A more proximal challenge to mobility is the clinical need for a well-fitting socket. Veterans who live near a clinic
can be repeat customers until a satisfactory fit is obtained, but about a quarter of all Veterans live in rural
communities far from VA Medical Centers. I am testing inexpensive digital scanning technology to remotely
capture a Veteran’s residual limb shape with the assistance of a caregiver or helper. My VA funded research will
determine if prosthetic sockets, made in part with remote study helper assistance, fit at least as well as prosthetic
sockets made entirely with in-person prosthetic services. Affordable advances in technology that improve access
to care and service delivery are clinically welcome.
Of course, a well-fitting socket is essential for mobility, but perspiration can quickly bring mobility to a halt due
to adherence problems. New to market are perforated liners that allow perspiration to seep away from the skin.
I am conducting a nationwide, decentralized clinical trial (n=180) to compare three clinically available products
intended to address problems of perspiration. The results are expected to identify the product that maximizes
stability, suspension, and comfort when activities and/or environmental conditions induce perspiration.
Lastly, a fan of science fiction movies might think biomechatronic limbs are soon to be within our reach. My team
and I have developed several microcomputer operated limbs with machine and deep learning algorithms to
predict movement intentions. One particularly intriguing problem we are exploring is how to respond to rapid
changes in loads such as when a person picks up or sets down a heavy item. However, in the short-term, clinicians
need more pragmatic studies. My team has recently completed a load carriage study intended to provide
recommendations on how an individual should carry a load (anteriorly, posteriorly, on the prosthetic limb side,
or on the intact limb side) and which of several different study feet are best for such activities.
The knowledge disseminated from my research will provide evidence to assist clinicians with their prescription
practice and guide the commercial development of new products. I expect both to lead to substantial quality of
life improvements for Veterans with lower limb amputation.

Public health relevance
PROJECT NARRATIVE (RELEVANCE TO VETERANS) VA surgeons perform more than 4000 major lower limb amputations annually. These Veterans are among the 623,000 Americans who live with a major lower limb amputation, the majority of whom were of diabetic or dysvascular etiology (4 out of 5) and the remainder mostly due to trauma. Another several thousand, also of traumatic etiology, stem from the U.S. involvement in enduring military conflicts overseas. These Veterans have all experienced a profound change in their lives. They walk slower and fall more often. Many incur injuries to their residual limb. Few find wearing a prosthesis comfortable. Why? Because the current state-of-the-art prosthetic restoration is no peer of the natural limb. My clinically relevant research aims to improve their mobility, reduce their risk of injury, and enhance their comfort by using innovative approaches to marry new technology with artisanal practice.